Addressing health disparities among understudied women in the deaf and hard of hearing population

The purpose of the administrative supplement (NOT-AG-18-039) is to expand existing research to focus on Deaf Women Health. Current widely used NIH-funded patient reported outcome measurement systems (PROMIS) include domains that assess global, physical, mental, and social health from the patient’s perspective. PROMIS is heavily dependent on English, which is a serious barrier to DHH patients who use American Sign Language (ASL) and demonstrate low English proficiency. We addressed this knowledge gap through innovative cross-cultural translation of patient reported survey in ASL and primary data collection from a large representative sample of adults with early deafness. In this administrative supplement for women health, we will follow the same protocol, as in the parent R01, to culturally adapt and linguistically validate women health-related measures. The sample will include 100 DHH mid-to-older women, providing adequate power for group analyses. This is further described in the research strategy section.

Public health relevance
PUBLIC HEALTH RELEVANCE PROMIS-Deaf profile is a patient reported outcome measure that is accessible in American Sign Language and English. Such measure that has been validated in these languages will allow future research and clinical trials to include deaf and hard of hearing population without barrier. For the purposes of the women health supplement, the inclusion of understudied, underrepresented deaf and hard of hearing women in patient outcomes research will broaden impact and generalize research findings. 1